Development of CapCell Scope for Metabolic Imaging of Tissue Heterogeneity and Therapy Response

Targeting and quantifying metabolic changes non-invasively is a powerful approach to facilitate diagnosis and
evaluate therapeutic response. Cellular metabolism involves a vital network of pathways for homeostasis,
growth, and survival and can shift from one nutrient pathway to another based on the extent of perfusion available
to the cells. Interest in cellular metabolism and tissue vasculature continues to expand across a broad range of
disciplines including neuroscience, cardiovascular biology, and the field of cancer research. Though there are
many bench-top microscopes and metabolic tools available to provide exquisite resolution and contrast for
metabolic or vascular imaging, these systems require extensive training and often have fields of view (FOV),
resolution, and wavelengths that fit only the most common use cases. Further, they require researchers to
transport animals to specialized facilities, and this limits access to longitudinal imaging. Additionally, there are
surprisingly few biomedical imaging technologies available to image both the global landscape and local spatial
variations of metabolic and vascular hallmarks in vivo. We propose to develop an optical imaging platform the
Capillary-Cell or CapCell to permit studies of metabolic reprogramming and heterogeneity across the laboratory
to clinical continuum. This technology will report on the major axes of metabolism, blood vessel architecture and
morphology of different biological systems including organoids and xenograft mouse models. Our work will lead
to the establishment of predictive biomarkers to support drug development, inform on drug choices and evaluate
the efficacy of drugs in bench research and in patients. The technology will be portable and turnkey and therefore
can be placed in individual labs instead of a central dedicated facility. This is essential to putting new biomarker
capabilities directly into the hands of laboratory scientists. The clinical translatability of the CapCell will focus on
breast cancer therapies. The CapCell will inform the selection of compounds for personalized management of
cancer patients in adaptive clinical trials and ultimately those in a standard clinical setting. Further, it will enable
the identification of successful drugs early in their development, thereby accelerating market approval for
candidate therapies. Lastly, this technology will be instrumental in understanding metabolic heterogeneity during
primary cancer formation and invasion and its modulation by oncogenic driver mutations and their inhibition. The
biological models will include human organoids and mouse models developed at UCSF. Patient-derived
organoids (PDO) will serve as a bridge between patients and mouse models – they can be created from patient
samples, and they can then be engrafted into mice, and Patient-derived xenografts (PDX) models can be used
to identify dynamic biomarkers associated with the risk of recurrence.

Public health relevance
Project Narrative Metabolic adaptation is essential to survival, and metabolic imaging either by itself or in combination with genomics, proteomics, and metabolomics can provide a holistic understanding of how cells adapt under varying physiological and pathological microenvironments as well as serve as a predictive marker of treatment success. The goal of this proposal is to develop a portable and versatile optical imaging platform called the CapCell to characterize the metabolism of subpopulations of cells with different phenotypes and the relationship of these cells with the local microvasculature. We will use this technology to elucidate how metabolic endpoints can inform on the growth and invasion of tumor cells into adjacent host tissue, elucidate how diverse types of therapeutics inhibit the downstream efforts of tumor-promoting oncogenes, and identify biomarkers that can inform the management of cancer therapy in patients.